Hot Spot Analysis of the Breast Cancer Susceptibility Protein

Abstract
Germline mutations in the breast cancer susceptibility gene (BRCA1) are heavily linked to familial breast and
ovarian cancers. Women who inherit these mutations are ~60% more likely to develop the disease. During
normal female development, critical windows of vulnerability correlate with the early onset of breast cancer.
These events coincide with a buildup of DNA lesions in mammary tissue as reactive oxygen species are
formed from the metabolic processing of estrogen. Damaged DNA, if left unrepaired, can perpetuate errors in
the genome. Reduced expression levels of the BRCA1 protein or BRCA1 mutations, compounded with
insufficient lesion repair, provide a tipping point toward cancer induction. At the molecular level, the intricate
details of these mechanisms are poorly understood. In the nucleus, BRCA1 associates with its binding partner
the BRCA1-Associated Ring Domain protein (BARD1) to help coordinate the repair of DNA modifications. The
BRCA1-BARD1 heterodimer performs these operations by interacting with other repair proteins, such as
BRCA2, at damaged sites on DNA. In this context, BRCA1 acts as a tumor suppressor to ensure fidelity in the
genome. Inherited mutations in BRCA1 can cause functional deficiencies in the protein that affect its job in
tumor suppression. Moreover, as decades of scientific research demonstrate BRCA1's multifaceted role in
DNA repair, information about the physical properties of BRCA1 are just coming to light. Improving our
knowledge of BRCA1's three-dimensional (3D) structure can provide new insights for therapeutic discovery. In
the proposed research, we will use a unique combination of cryo-Electron Microscopy (EM) imaging
technology and biochemical tools to study the differences in wild type and mutated BRCA1. Our preliminary
data suggests that changes in mutated BRCA1 in response to oxidative damage leads to changes in a
“modification hot spot” on the protein. We will test this idea across multiple breast cancer cells lines, then
develop a new enzymatic approach to attenuate this effect in cancer cells. Our combined biochemical and
structural biology strategies will provide a new lens to view the physical nuances of the BRCA1 structure for
the first time. This information will shed light on BRCA1 deficiencies relate to cancer susceptibility.

Public health relevance
Public Health Relevance Statement Hereditary breast cancer is a genetic disease for which there is no precise form of targeted therapy. We will investigate the molecular actions of the breast cancer susceptibility protein, BRCA1, that is heavily linked to hereditary forms of breast and ovarian cancer. Using state-of-the-art imaging tools, we will investigate BRCA1’s actions in the cell’s nucleus and determine how specific errors in the protein fuel cancer susceptibility.